Mechanisms of Human Cytomegalovirus Latency in Primary Human Hematopoietic Cells

PROJECT SUMMARY
Human cytomegalovirus (HCMV) is a β-herpesvirus that establishes a lifelong latent infection in its host.
Reactivation from latency can result in life-threatening disease in immune deficient individuals, particularly
stem cell and solid organ transplant recipients. Our research program has a long-standing focus on defining
HCMV determinants and host interactions at the mechanistic core of latency and reactivation. In previous
funding periods, we defined a polycistronic locus within the ULb' region of the HCMV genome that spans the
genes UL133-UL138. Within this region, we have identified virus-coded repressors and activators of virus
replication. UL138 represses replication for latency, whereas UL135 activates replication for reactivation, in
part, by overcoming the repressive action of UL138. UL135 and UL138 regulate EGFR with opposing effects
and together comprise a switch to control viral latency and reactivation by regulating host signaling. Recently,
UL136 has emerged as a key modulator of this switch. UL136 encodes 5 alternant protein forms or isoforms
(p33, p26, p25, p23, and p19, based on their molecular mass) that differ only in their N-terminal sequences.
UL136 isoforms accumulate at later times relative to UL135 and UL138 in productive infection, requiring the
onset of HCMV genome synthesis for maximum expression. Some UL136 isoforms are required for
reactivation (p33 and p26 isoforms), while others function in latency (p23 and 19 isoforms). However, nothing
is known about the mechanism by which UL136 isoforms function or their interplay with other UL133-UL138
proteins to regulate latency and reactivation. Intriguingly, the full-length, membrane-bound isoform of UL136
(p33) is unstable and targeted for rapid turnover (t1/2≤1h), whereas other UL136 isoforms are stable (t1/2>6h).
Stabilization of p33 by specific mutation results in a virus that cannot maintain latency and replicates, indicating
that its rapid turnover is critical for maintenance of latency. From these findings, we hypothesize that the
UL136 isoforms modulate the UL135/UL138 switch to reinforce decisions to stably maintain or exit latency. We
propose 3 aims to address this hypothesis. Aim 1 will determine how UL136 p33 is targeted for rapid turnover
and the significance of its destabilization to the decision to maintain latency or to reactivate. Aim 2 will define
epistatic interplay between the UL136 isoforms and with other UL133-UL138 proteins to modulate latency and
reactivation. Aim 3 will identify UL136-host interacting partners to define the mechanisms by which UL136
modulates the switch between latency and reactivation. Our work reveals new directions in HCMV latency-
specifically, distinct roles for each UL136 isoform in modulating decisions to maintain the latent infection
(UL138-dominant) or to reactivate (UL135-dominant). Understanding the mechanisms by which UL136
isoforms modulate the tipping point between latency and reactivation will expand the mechanistic paradigms
surrounding herpesvirus latency and reactivation.

Public health relevance
PROJECT NARRATIVE Viral latency—a means by which viruses maintain life-long infections with their host—is poorly understood and underlies potential for recurrent viral disease and other complications. Understanding the mechanisms of viral latency and reactivation from latency is a major impediment to developing therapeutic strategies to cure or control herpesvirus infections. We have identified human cytomegalovirus (CMV) genes that control latency and reactivation and seek to understand how these viral genes target cellular process in the host, which will ultimately identify new targets for novel antivirals aimed at eliminating or controlling latent virus infection and prevent disease in immune compromised individuals, including transplant patients.